STRUCTURAL VARIATION IN NEUROLOGICAL DISEASE

ABSTRACT
During the previous two decades it has become apparent that genomic rearrangements are often the type of
mutation that underlies neurological disease. This is so not only for neurodevelopmental disorders such as
intellectual disability (ID) and different recognizable patterns of human malformation (e.g. Potocki-Lupski
syndrome), but also for late-onset adult neurological disorders such as Charcot-Marie-Tooth disease.
Moreover, genomic rearrangement can often underlie complex traits and sporadic diseases such as Parkinson,
Alzheimer disease and other neurodegenerative processes. Contrary to prior interpretations, experimental
evaluation of disease associated genomic rearrangements has often documented that they can be much more
complex than anticipated. Complexities can occur at individual loci and give specific patterns for complex
genomic rearrangements (CGR) as observed on genome-wide array CGH; such as duplication - normal -
duplication (DUP-NML-DUP), or a triplication embedded within duplications (DUP-TRP-DUP). Furthermore,
complexities can occur on a genomic level leading to complex chromosomal rearrangements (CCR) and the
phenomena of chromothripsis observed both in cancer and neurodevelopmental disorders, as well as an
unusual experimentally observed pattern of multiple de novo copy number variants (CNVs) spread apparently
randomly throughout the genome. The elucidation of mechanisms that can generate such complexities is an
emerging field. We propose to further characterize CGR that have been found in association with neurological
disease. Specifically, we will investigate: 1) CGRs that consists of: i) a DUP-NML-DUP pattern and ii) a
pattern of a triplicated segment in inverse orientation embedded within a duplicated segment of the genome
(DUP-TRP/INV-DUP); these are newly observed types of CGR with one proposed mechanism elucidated in
our previous application; 2) The mechanism for recurrent triplications; 3) Elucidate the underlying molecular
characteristics and breakpoint junctions of CGR that are accompanied by long genomic stretches of absence
of heterozygosity (AOH), and resulting in both genomic (CGR) and genetic (AOH) alterations; 4) Alu-Alu
rearrangements and their role in genomic instability and disease and 5) We will attempt to isolate a gene
important to the phenomena of multiple de novo CNV seemingly randomly distributed throughout the genome.
The experimental approaches to be utilized to accomplish each one of these specific aims are now within our
reach. These studies predominately require genomic approaches that enable genomewide assays of variation
such as array comparative genomic hybridization, genomewide SNP chips, whole exome sequencing (WES),
whole genome sequencing (WGS), and other mapping and molecular approaches for the delineation of
specific breakpoint junctions. It is anticipated these studies will characterize these novel types of
rearrangements and lend further insight into basic molecular mutational mechanisms driving gene and genome
evolution and that can cause the myriad of neurological diseases.

Public health relevance
PROJECT NARRATIVE The project will provide new insights into mechanisms underlying complex genomic changes resulting from DNA rearrangements - a common cause of neurological disease. This will enable better diagnostics and potential new avenues for therapy by the correction of gene dosage further supporting the Precision Medicine Initiative. Such genomic rearrangements cause gene copy number variations (CNV) resulting in neurodevelopmental disorders including intellectual disability, behavioral disorders such as autism, psychiatric conditions such as schizophrenia, and neurodegenerative diseases such as Alzheimer, Parkinson and Charcot-Marie-Tooth disorders.